EHR-based Genomic Risk Assessment and Management for Diverse Populations

PROJECT SUMMARY/ABSTRACT
Recently, large-scale genome-wide association studies (GWAS) provide evidence for a substantial polygenic
contribution to the risk of many common complex diseases. However, most of these studies were performed in
Europeans, and new data and methods are necessary to tailor polygenic risk prediction to non-Europeans, to
ensure that genomic stratification does not further exacerbate health disparities. The overarching goal of the
eMERGE-IV network is to leverage genetic and electronic health record (EHR) data for diverse populations to
design, validate and test the clinical utility of ancestry-tailored polygenic risk scores for common diseases. As a
current member of the eMERGE network, Columbia University has significantly advanced its goals, having
recruited over 2,500 diverse patients for sequencing and return of actionable findings, leading the effort to
transition the network to the OMOP Common Data Model to improve the efficiency, accuracy, reproducibility and
portability of electronic phenotypes, and contributing a widely-adopted XML parser for structuring genetic test
reports. Since our last application, the Columbia Precision Medicine Initiative has also grown and now includes
participation in several national initiatives, such as the All-of-Us program, in which we have demonstrated our
ability to rapidly recruit patients under-represented in biomedical research. Our scientific expertise combined
with our strong tradition of patient-centered research and community engagement in a socioeconomically,
racially, and ethnically diverse community of Northern Manhattan, positions us to successfully contribute as the
Enhanced Diversity Clinical Site of the eEMERGE-IV network. We will leverage our prior experience with
eMERGE, scientific expertise, and knowledge gained from participation in other national precision medicine
initiatives to develop, optimize, validate and disseminate ancestry-tailored genomic risk assessment and clinical
management tools. In Aim 1, we will continue to advance electronic phenotyping by contributing sharable natural
language processing tools for converting clinical text into OMOP-based discrete data and facilitating phenotype
interoperability. In Aim 2, we will develop and optimize accurate ancestry-tailored genome-wide polygenic
predictors, integrate them with clinical risk predictions, and test their performance in diverse populations. In Aim
3, we will investigate ELSI issues related to the return of health risk predictions to diverse patients by ascertaining
patients’, clinicians’, and IRB members’ views through focus groups. In Aim 4, we will develop portable EHR
plug-ins to facilitate prospective risk communication and management using integrated genomic data, family
history, and clinical data. In Aim 5, we will recruit 2,500 diverse patients and use a randomized controlled trial
design to assess the impact of return of genomic prediction on the accuracy of risk perception, health
surveillance, and risk reducing measures. This proposal will address major knowledge gaps in genetic risk
assessment for diverse populations, and the solutions and knowledge gained will be broadly applicable to
precision medicine for common complex traits across many clinical specialties.

Public health relevance
PROJECT NARRATIVE Advances in precision medicine are making it increasingly possible to tailor healthcare decisions based on the individual patient’s genomic risk profile. However, large-scale validation studies of risk prediction accuracy and its clinical utility are severely lacking in diverse populations. The goal of this eMERGE-IV project is to leverage genetic and electronic health record data for diverse populations to design, optimize, validate and test the clinical utility of ancestry-tailored polygenic risk scores for common diseases of high public health impact.